Project 4: Epigenetic modifiers of regulatory T cell function following viral pneumonia

PROJECT SUMMARY/ABSTRACT – ESI-LED PROJECT 4
Influenza and COVID-19 exert a disproportionate impact on older patients. Influenza A virus and SARS-CoV-2
cause severe viral pneumonia, injuring the lung to induce the acute respiratory distress syndrome (ARDS), for
which anti-viral therapies have limited efficacy and ICU interventions remain supportive. Older patients with virus-
induced ARDS experience slow recovery, leading to protracted ICU stays that often herald the compounding
multi-morbidity and functional limitation observed among elderly survivors of severe respiratory infection. We
reason that activation of youthful resolution and repair pathways in older patients with severe viral pneumonia
will potentiate recovery to extend the health-span of older ICU survivors. CD4+Foxp3+ regulatory T (Treg) cells
coordinate resolution and repair following experimental acute lung injury. These cells appear in the alveolar
spaces of patients with ARDS and display epigenetic and transcriptional signatures predicted by murine
experiments. In contrast with young mice, Treg cells from aged mice exhibit a cell-autonomous impairment in
pro-recovery function following influenza and fail to upregulate the epithelial growth factor amphiregulin.
Mechanistically, epigenetic alterations in DNA methylation signatures represent a hallmark aging process that
modulates Treg cell function, and Treg cells from aged mice and mice with genomic instability-induced premature
aging display a striking DNA hypermethylation signature compared with Treg cells from young mice. DNA
methyltransferase (DNMT) activity and the DNMT adapter Uhrf1 mediate DNA methylation signatures in Treg
cells, but whether these factors induce DNA hypermethylation in Treg cells during normal and genomic instability-
induced aging to impair Treg cell pro-recovery function following viral pneumonia in aged hosts remains
unknown. We hypothesize that DNMT activity and Uhrf1 induce DNA hypermethylation in Treg cells during
aging to impair Treg cell reparative function following severe viral pneumonia in older hosts. We propose
three Specific Aims, which use cutting-edge murine systems, a translational human case-control study, and novel
computational platforms to test our hypothesis. Aim 1 will reveal whether DNMT activity or Uhrf1 is necessary
to induce DNA hypermethylation in Treg cells during aging. In Aim 2 we will determine whether transient loss of
DNMT activity or Uhrf1 in Treg cells during recovery from influenza restores the transcriptional programs and
amphiregulin-dependent function present in youth but lost with aging. Aim 3 will elucidate the association
between age, alveolar Treg cell DNA methylation signature, and 30-day mortality in selected patients with severe
influenza A or COVID-19 viral pneumonia. Our proposal will establish causal evidence linking drug-targetable
mechanisms to detailed physiologic readouts. Elucidating these causal links will enable the development of pro-
recovery therapeutic approaches for severe influenza, COVID-19, and other causes of ARDS in older patients.

Public health relevance
PROJECT NARRATIVE – ESI-LED PROJECT 4 A Project Narrative is not required per instructions stated in the Funding Opportunity Announcement PAR-18- 405, Section IV. Application and Submission Information, ESI-Led Project, Research & Related Other Project Information (ESI Project), “Project Narrative: Do not complete.”